Microbial and host biomarkers in colorectal cancer oncogenesis

PROJECT SUMMARY
Colorectal cancer (CRC) is the second leading cause of cancer death in the U.S.
Fusobacterium nucleatum (Fn), a gram-negative oral anaerobe, is one of the most prevalent
species implicated in CRC.
Our previous work demonstrated that Fn stimulates colorectal cancer growth via its unique
adhesin FadA, which binds E-cadherin and activates Wnt/β-catenin signaling. FadA undergoes
dramatic biochemical changes to become amyloid-like under stress and disease conditions,
converting Fn from a benign commensal to a virulent pathogen. Amyloid FadA preferentially binds
to cells expressing Annexin A1 (ANXA1), which is upregulated in proliferating CRC cells and is
critical for CRC growth. Upon binding to CRC cells, Fn further stimulates ANXA1 expression via
amyloid FadA worsening prognosis. We hypothesize that amyloid-like FadA and ANXA1 are novel
biomarkers in CRC oncogenesis. To test this hypothesis, we propose the following interrelated aims:
(i) Mechanistic and therapeutic investigation of amyloid-like FadA in CRC; and (ii) Mechanistic and
therapeutic investigation of ANXA1 in CRC. Results from this study will significantly advance our
understanding of microbes in CRC and identify potential therapies, thus will have tremendous
translational potential.

Public health relevance
PROJECT NARRATIVE Colorectal cancer is the second leading cause of cancer death in the U.S. This study investigates microbial and host biomarkers in colorectal cancer oncogenesis. The results will significantly advance our understanding of colorectal cancer and identify novel therapeutic strategies.